Minnesota Craniofacial Research Training Program

The Minnesota Craniofacial Research Training Program is a direct response to PAR-15-
101, Institutional Training for a Dental and Craniofacial Research Workforce (T90/R90),
and the national need to train the next generation of biomedical scientists to work on
significant problems in craniofacial, dental, and oral health research. The mission of the
program is to engage trainees in novel, mentored research that is fundamental to
biology and human health, and translational research that expands the frontiers and
scope of craniofacial, dental, and oral health. To foster our mission and ensure strong
mentorship and inter-disciplinary research training, a non-hierarchical and highly
consultative administrative structure is in place. Trainees engage in research training
opportunities with groups of experienced, dedicated and well-supported mentors in
Neuroscience, Microbiology and Immunology; Cancer Biology; Developmental Biology,
Molecular Genetics, and Stem Cells; Biophysical Sciences; Nanotechnology, Materials
Sciences, and Tissue Engineering; and Genomics, Proteomics, Structural Biology, and
Computational Biology. Trainee T90 programmatic options include DDS/PhD
(DSTP), predoctoral PhD, postdoctoral fellows, and R90 postdoctoral PhD for
international dental clinicians. The Minnesota Craniofacial Research Training program
builds upon our considerable training experience, outstanding applicant pools and
partnerships, new initiatives to recruit and retain DSTP fellows, and appreciation for
creative mentored research training. Our alumni work at the state-of-the-art to expand
the frontiers of biology and craniofacial, dental, and oral health research.

Public health relevance
The Minnesota Craniofacial Research Training Program is a direct response to PAR-15- 101. The program will continue to engage trainees in novel, mentored research training that is fundamental to biology and human health, and translational research that expands the frontiers and scope of craniofacial, dental, and oral health. Trainee T90 programmatic options include DDS/PhD (DSTP), predoctoral PhD, postdoctoral fellows, and R90 postdoctoral PhD for international dental clinicians. Our alumni work at the state-of-the-art to expand the frontiers of biology and craniofacial, dental, and oral health research.